Polyalanine Tails: A Novel Type of Protein Modification Implicated in Neurodegeneration

Among the costliest diseases to society, and with rising prevalence in an aging population, neurodegenerative
diseases pose a public health challenge. However, there are few options available for their treatment, and
without pathomechanisms being sufficiently elucidated, one's ability to generate a rationale for interventions is
greatly limited. Our studies are expected to address this barrier by establishing new etiological factors and
molecular mechanisms of mammalian neurodegeneration. One such mechanism is Ribosome-associated
Quality Control (RQC), that mediates the degradation of incomplete polypeptides produced by ribosomes that
stall during translation. Key factors working in RQC are the Ltn1/Listerin E3 ubiquitin ligase and its partner,
NEMF (Rqc2 in yeast). PI Joazeiro has previously found that Ltn1 mutation causes neurodegeneration in mice.
PI Cox has more recently identified two independent mutations in mouse Nemf causing motor neuron disease
and used this to knowledge to identify previously undiagnosed patients with a similar neuromuscular condition
that inherited causative mutations in the human NEMF gene. In several ways, Ltn1-ENU and Nemf-ENU mice
phenocopy each other, thus strengthening the connection between RQC dysfunction and neurodegeneration.
The proposed studies are aimed at understanding molecular mechanisms underlying neurodegeneration
caused by NEMF loss of function. We focus our analyses on a recently-discovered activity of NEMF that is
conserved from bacteria to humans–the modification of aberrant nascent chains with C-terminal Alanine tails
that have a proteolytic function. Based on our preliminary data, we hypothesize that NEMF-mediated Ala tailing
protects neurons against degeneration. Results of these studies are expected to provide critical understanding
of how defects in protein quality control lead to neurological disease.

Public health relevance
The goal of this basic research proposal is to characterize a novel enzymatic activity whose loss we find to be associated with neurodegeneration in mice and humans, and to determine to what extent this activity plays a protective role against cytotoxicity. By elucidating molecular mechanisms underlying neurodegenerative disorders, the proposed work is expected to open the way to the development of new therapeutic rationale and approaches.